Pharmacy-centered Rapid ARV Network: Capacity-building for status-neutral ART/PrEP services within Southern community pharmacies

Modified Project Summary/Abstract Section
HIV disproportionately affects the Southern United States with the highest burden of new infections. While
biomedical HIV prevention strategies, such as pre-exposure prophylaxis (PrEP) and treatment as prevention can
effectively prevent HIV acquisition and transmission, innovative strategies are still needed to ensure these tools
are employed in the communities most impacted by the epidemic. Alabama, one of seven priority states in the
U.S. Department of Health and Human Services Ending the HIV Epidemic initiative, recently permitted
collaborative practice agreements between physicians and pharmacists. Over half of all pharmacies operating
in Alabama are community-based with many operating in areas of the state of higher HIV incidence. Rapid status
neutral approaches can improve linkage to HIV service delivery, and pharmacy-based HIV testing in pharmacies
has been effective in other regions. However, critical gaps remain in understanding how to effectively incorporate
HIV testing and service delivery in pharmacy settings in Alabama and other regions of the Southern US. To close
that gap, this proposed study will pursue two specific aims: (1) Evaluate key determinants for implementation of
a test-to-treat, status neutral rapid antiretroviral (ARV) intervention into independent pharmacy settings through
concurrent mixed-methods; (2) Develop and refine a multi-component implementation strategy to integrate HIV
testing, PrEP, and ART in routine pharmacy-based practice. Upon completion of our proposed research, our
inter-disciplinary team, which includes experts in infectious diseases and HIV PrEP/ARV service delivery,
implementation science, community-engaged research, and pharmacy care delivery, will lead to a multi-site type
III implementation trial of PrEP service delivery at community pharmacies across the South.

Public health relevance
Modified Public Health Relevance Section The proposed project begins the process of launching status neutral delivery of rapid antiretrovirals (antiretroviral therapy for treatment and prevention) to persons living in the South, diagnosed with HIV and more vulnerable to the diagnosis, by developing implementation strategies to support test-to-treat, same-day service delivery located at independent pharmacies and facilitated through development of collaborative practice agreements. We will evaluate critical key determinants to implementation resulting in policy paradigm shifts in a state where pharmacy-initiated HIV testing and care is novel. This project is responsive to national priorities outlined by the Ending the HIV Epidemic initiative as well as the NIH Research Funding Announcement (RFA-MH-25-185) by evaluating a new strategy to increase uptake of highly efficacious evidence-based interventions (i.e., rapid start ART) within a local community with HIV incidence and an EHE priority state.